Prospective Study of Youth Assets and Teen Pregnancy

More than 800,000 teenagers become pregnant each year. Youthdevelopment programs, which are based on the belief that assets can insulate youthfrom engaging in harmful behaviors, are one promising approach to preventing teen pregnancy. However, to date there is little hard scientific evidence to suggest that youth assets are causally related to a reduction in teen sexual and related risk behaviors. The Youth Asset Study (YAS), a 3-year project funded by the CDC, is currently underwayto test the asset/teen sexual behavior causal relationship. The current proposalis to requestfunding to extend the YAS so that waves 4 to 6data can be collected and analyzed. The YAS is the first study to specifically and comprehensively investigate, using a developmental age group approachand a longitudinal study design, the relationships amongyouth assets and community factors and the strength of their relationships to youth sexual behavior, teen pregnancy, and related risk behaviors (e.g., alcohol and drug use). Currrently, we are tracking a cohort of youth (baseline ages 12 to 17)and their parents (N=1,000 youth/parent pairs) in a 3-year longitudinal study. Using in-home, in-person interview methods, the study team collected wave 1 data from 1,000 youth/parent pairs and wave 2 data from more than 100youth/parent pairs (to date). The retention rate is 94%. Wave 3 data will be collected in 2005 and 2006. This proposal encompassescollecting and analyzing data from waves 4 to 6 from the same youth/parent pairs. Byfollowing these youth through their teenage years and into early adulthood, we will investigate the role of assetsand community factors in influencing the health behavior and outcomes of youth as they transition into older teenand young adulthood. The YAS goals directly contribute to several Healthy People 2010 objectivesincluding objectives9-7 (i.e., Reduce pregnancies among adolescent females) and 25-11 (i.e., Increase the proportion of adolescents whoabstain from sexual intercourse or who use condoms if currently sexually active). The YAS is a scientifically rigorous evaluation of hypothesized relationships among community factors, assets and youth risk behaviors, which is of critical interest to the CDC, state and local health departments,and other organizations working in adolescent health.